BIOMEDICAL RESEARCH AT BARRY UNIVERSITY

The Goals of the MBRS RISE program at Barry University, are to: 1. Increase student and faculty biomedical research skills; 2. Increase student academic preparedness; 3. Improve the research building capacity of the institution. To achieve these goals we have determined eight Measurable Objectives: 1. Increase the number of students involved in biomedical research by 10 students annually. 2. Increase the number of students experiencing a summer research internship by 40%. 3. Increase the number of research faculty involved in biomedical research by 15%. 4. Increase the number of student and faculty presentations at scientific meetings by an average of 15%. 5. Increase the number of MBRS RISE student acceptances into Ph.D. programs by 5%. 6. Increase the average GRE sub scores by an average of 10%. 7. Increase the number of publications from faculty by an average of 10%. 8. Increase the number of faculty research grant applications by an average of 7%. Two developmental activities are designed to achieve these objectives: Student Development, consisting of Research Building and Graduate School Readiness; and Faculty Research Building. Research Building is students' "hands-on" involvement in research beginning with them developing basic research skills in the Introduction to Research workshop, gaining confidence to conduct meaningful research through on-campus research, and becoming more aware of the commitment required of a researcher through the summer research internships. MBRS RISE students conducting research will make oral/poster presentations at the Biomedical Seminar Series, at scientific meetings, and at the colloquium. The number of presentations at scientific meetings and acceptances into Ph.D. programs will increase. Graduate School Readiness is GRE preparation sessions, tutoring sessions in science core courses, and education in the graduate school process. The GRE scores and the number of acceptances into Ph.D. programs will increase. Faculty Research Building is faculty strengthening their research skills through a summer internship. The number of faculty involved in research, and the publications, presentations at scientific meetings, and research grant applications will increase. The activities will begin in the sophomore or junior year of biology and chemistry majors and continue into the senior year. Full-time faculty in the School of Natural and Health Sciences and in Chemistry will participate in the activities.